NHLBI PROJECT MANAGEMENT SUPPORT SERVICES (PMSS)

Provide scientific portfolio, program, and project management to a variety of high-priority Institute initiatives. Align dedicated resources to manage complex scientific endeavors, broad and diverse Institute portfolios, multi-year programs and projects, and time-sensitive critical tasks. Perform integrated project management across the organization.